UKY DENTAL COBRE: ADMINISTRATIVE AND EDUCATIONAL CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Administrative/Educational Core of the CBBO/SD has facilitated the research and training goals of the COBRE by: (1) To schedule and organize meetings for the CBBO/SD participants; (2) To organize meetings of the Scientific Advisory Committee (SAC); (3) To provide fiscal administration and accounting; (4) To interface with institutional administration in new faculty recruitment; (5) To oversee the funding of new pilot projects; (6) To interface and provide appropriate reporting to the NIH and other regulatory agencies; (7) To sponsor and organize research career development and training opportunities;and, (8) To provide outcomes assessment of the CBBO/SD.